Building equity in cancer screening through research: The Siteman Catchment CSRN Hub

To bring equity principles to research and practice of cancer screening and early detection, we will build a
CSRN ACCESS Hub at Siteman Cancer Center. Improving early detection is critical to reducing the growing
burden of cancer in our society and has the potential to reduce cancer health disparities. For this to happen,
research must not only include groups who have traditionally been marginalized and under-represented in
research, we must consider those communities in research design and conduct. Research conducted at the
Siteman Catchment Hub will prioritize rigor, equity, diversity, and inclusion of under-represented
populations. We represent a collaboration of Siteman Cancer Center and seven community-based healthcare
systems in Missouri and Illinois. Led by an experienced multi-disciplinary team, our time-tested administrative
structure engages representation from participating sites, community partners, community-based clinicians,
and institutional experts in this endeavor. We draw on the deep clinical research infrastructure and supports at
Siteman Cancer Center and Washington University School of Medicine, and organized our Hub into four cores:
Administrative, Participant, Study Protocol, and Data. We are founded on intentional integration, engagement,
and transparent communication strategies. The specific aims of our Center are: (1) Contribute to the
scientific development of CSRN research including an initial Multi-Cancer Detection Vanguard study that is
inclusive of diverse populations and considers health equity in its approach; (2) Recruit and retain diverse
participants to CSRN studies with representation across rural and urban, income and insurance, and racial
and ethnic backgrounds; and (3) Implement CSRN protocols, including diagnostic follow-up as needed.
Building on our experience conducting research that includes groups traditionally under-represented in
research, we propose to enroll 2000 individuals across our region into the Vanguard study, with at least 50%
from rural areas and 25% from racial and ethnic groups under-represented in research, and with purposeful
inclusion of low-income and under/ un-insured adults. We will work closely with community partners to support
recruitment and ensure protocols are accessible to diverse individuals. The Siteman Catchment Hub has
several notable strengths and innovations. First, we serve and are committed to populations that are medically
underserved and under-represented in clinical research. Second, our multidisciplinary leadership team is
dedicated to equity and inclusion, and has deep experience with cancer screening research and clinical trials.
Third, we engage organizational partners and community partners in Hub leadership. Fourth, we have strong
institutional support and infrastructure that will support the conduct of this research, access to quality data, and
rigor in our approach. We need sound evidence to inform advances in cancer screening and early detection,
including considering feasibility and acceptability of future implementation in diverse settings and populations.
The Siteman Catchment CSRN Hub will deliver on that need.

Public health relevance
Improving screening and early detection is crucial for reducing the growing burden of cancer in our society. Such efforts have the potential to reduce cancer disparities and inequities if research is designed and conducted with equity and accessibility in mind. For the Cancer Screening Research Network, the Siteman Cancer Center Catchment Hub is focused on building equity in cancer screening through research and engaging diverse community members across Missouri and Illinois in this effort. Our multi-disciplinary team and region-wide partners are committed to reducing the burden of cancer for all.